Community Engagement and Dissemination Core

Modified Project Summary/Abstract Section

The overarching goal of the Community Engagement and Dissemination (CoED) Core is to build community research capacity to address health needs to create a foundation towards sustainable partnerships among Community-Based Organizations (CBOs) and academic partners. Further, this core is charged with delivering findings via community-relevant messages in English and/or Spanish as well as to the scientific community. Foundational theories for partnership activities include using the NIMHD Research Framework, Social Determinants of Health, and Syndemics to understand the scope of health needs to promote healthier living in our U.S.-Mexico border community. Initial activities include establishing key priorities for the five-year project. The CoED Core focuses on knowledge and skills development for the community-investigator partnerships through the Pilot Project Program (PPP) and Community Engaged Mentorship (CEM) in the Investigator Development Core for understanding and conducting ethical, mutually beneficial, culturally appropriate, and meaningful community-based participatory research. The Core will use the Community Academic Partnership for Health Sciences Research (CAPHSR)’s Guiding Principles and Research Expectations for the PPP and community investigators. Additional activities target the skills to deliver health messages in a culturally and linguistically inclusive manner (English and Spanish) to reach U.S.- Mexico border constituents. The Core will use a Dissemination Planning Matrix to identify relevant strategies and media for communicating health needs and ultimately research findings to the Community Based Organization (CBO) stakeholders and to the community at large. The PPP teams will provide annual writing workshops to engage and integrate the community voices when writing for a scientific audience. To further community integration, online writing groups will be implemented to involve community members in the co-creation of the writing process. This multi-layered approach to engaging community voices in translational research and dissemination will result in an increased capacity to identify, evaluate, address, and communicate health findings to the U.S.- Mexico border community. Our center builds on a strong foundation of demonstrated commitment for the unique diversity of our bilingual, binational, multicultural communities, trajectory of effective community-engaged scholarship and partnerships, a solid record of intellectual capacity and robust support from community-based organizations. The CoED team with demonstrated community engaged scholarship will support the goals of the Investigator Development core and the center as a whole to advance community engaged transdisciplinary Hispanic health disparities research. Our ability to identify and develop community engagement and dissemination opportunities will leverage our strengths and continue to adapt and propel healthy communities.